Circadian reprogramming in cellular senescence

PROJECT SUMMARY/ABSTRACT
Aging and age-related diseases have become a public health crisis. Circadian rhythms become dysfunctional
with age and disrupted circadian rhythms result in elevated risk for diseases that are associated with aging. The
proposal aims to improve our understanding of the bi-directional relationship between aging and circadian
rhythms. This fellowship application will help train the candidate toward the goal of becoming an independent
investigator at an academic institution in the field of circadian aging.
A major driver of age-related disease is cellular senescence. There is literature evidence to suggest circadian
disruptions result in elevated in cellular senescence. Interestingly, there is also evidence that senescent cells
display circadian dysfunction. Mechanisms that govern these processes are incompletely understood and require
further investigation to delineate. Our preliminary data suggests expression levels of prominent players in the
cellular senescence program are dependent on expression of Bmal1, a core clock component. Further, we have
identified that p21, a cell-cycle protein also responsible for driving cellular senescence is highly upregulated at
night, but this rhythm is disrupted with circadian misalignment, suggesting the clock is responsible for regulating
its expression. We have also identified that both senescence status and treatment with exogenous SASP factors
can robustly alter clock protein, Per2 expression rhythms over time. Finally, we have identified that increased
markers of cellular senescence and disrupted circadian behaviors coincide with increased age in mice. Taken
together, we hypothesize that the molecular clock regulates cellular senescence and that cellular senescence
drives circadian dysfunction with age. To test this, we designed these aims: Aim 1: Determine how the molecular
clock contributes to cellular senescence. Aim 2: Define the rhythm of senescent cells and determine how they
influence the rhythm and circadian functions of neighboring non-senescent cells.
We will use both in vivo and in vitro approaches to strategically manipulate the molecular clock and cellular
senescence to disentangle their effects on one-another. Using state-of-the-art single-cell imaging techniques
and innovative treatment strategies, this proposal will fill in significant gaps in our understanding of mechanisms
driving age-associated disease. Further, the candidate will also undertake a rigorous training program at UT
Health San Antonio designed to enhance critical thinking and presentation skills, scientific productivity, and
successful entrance into a position as an independent researcher at an academic institution. The proposed
studies are significant because they will explicate a currently understudied reciprocal relationship between
circadian rhythms and cellular senescence. A better understanding of the underlying biological processes that
drive aging will undoubtedly provide insight toward development of therapeutic interventions capable of
ameliorating an array of diseases. This proposal will also support the scientific endeavors and training of a young
scientist with significant potential to run her own state-of-the art research program in the future.

Public health relevance
Project Narrative Disrupted circadian rhythms and aging are both associated with disease risk. Cellular senescence is a recently defined driver of diseases which occur with age. This proposal aims to better understand the relationship between cellular senescence and circadian rhythms with regard to age-related disease. Discoveries made from this study will provide novel insight for better therapeutics targeting aging and age-associated diseases.